Regulation of B cell Responses in SLE and Other Autoimmune Diseases

Abstract
On behalf of the ACE network, the Emory ACE Fund Management Core (EAFMC) at Emory
University proposes to continue to manage two funds. The first will be the Clinical Project Fund,
which will support all of the Clinical Projects (ClinProj) within the ACE. The second will be the
Collaborative Research Fund (CRF). The CRF will provide funding support for the Collaborative
Projects of the ACE, as well as additional studies that are added for achieving the ACE research
agenda. It is estimated from the RFA that the AFMC will manage $3.2M in direct costs associated
with these projects and that these will occur through about 100 consortium agreements emanating
from up to 50 different sites. It will accomplish this through the following aims: (1) Continue to
enhance the administration and management of the clinical and collaborative projects; (2)
Streamline the development of budgets and consortium agreements; (3) Establish templates for
the CliniPrj and CRP budget agreements; (4) Implement procedures to pay invoices and resolve
problems and (5) Develop procedures for accountability, communication and reporting to the ACE
Steering Committee and NIAID; all by utilizing the (6) EAFMC Templates developed.

Public health relevance
Project Narrative Not required for this component.